Microscopy system upgrade

PROJECT SUMMARY/ABSTRACT
Two large macromolecular machines, the spindle and kinetochore, coordinate chromosome segregation at cell
division. Errors in their function can lead to cancer and birth defects. While we now know nearly all the
molecules required for mammalian spindle and kinetochore function, how they collectively give rise to these
machines’ emergent physical properties remains poorly understood. Our long-term goal is to uncover the basic
physical design principles of robust and accurate mammalian chromosome segregation. How do thousands of
nm-scale molecules, pushing and pulling, give rise to the spindle’s µm-scale steady-state architecture and
mechanics? How do hundreds of kinetochore molecules work together to ‘compute’ attachment signals for
decision-making, and to robustly grip microtubules? This knowledge gap persists because we cannot currently
reconstitute these machines in vitro, and lack tools in vivo. To close this gap, we need approaches to finely
control molecules and directly exert forces inside dividing mammalian cells – which we recently developed.
First, we aim to define the mechanisms and functions of the spindle’s emergent architecture and
mechanics. (i) Based on our findings, we will test the idea that opposing stresses in the spindle are not
required to give it a steady-state structure, but are instead required to give it mechanical and functional
stability. Further, we will define in vivo and in vitro how active and passive forces contribute to building a
steady-state spindle. (ii) To uncover the function of the spindle’s specific steady-state shape, we developed an
optogenetic approach to acutely and locally control spindle architecture. We will use it to test the role of given
architectural modules in space and time through mitosis. (iii) To define the mechanisms underlying the steady-
state spindle’s mechanical robustness, we will use microneedle manipulation to deform the spindle, which we
recently adapted in mammalian cells, and modeling. Second, we aim to define how the kinetochore’s
molecules together enable it to ‘compute' attachment information and robustly grip microtubules. (i) Based on
our recent finding that only a few bound microtubules are needed for a kinetochore to allow anaphase, we will
quantitatively rewire kinetochore composition to test models for the origin of this exquisite microtubule
sensitivity. (ii) Using biophysical approaches we developed to remove and exert forces on kinetochores in vivo,
we will define the mechanisms giving rise to the kinetochore’s specialized, strong and dynamic grip.
Together, this will provide a framework for understanding, targeting, and rewiring the physical
processes of chromosome segregation for both basic and therapeutic purposes. This proposal is innovative in
that it tests new hypotheses about the connection between molecular and cellular-scale events, and provides
new tools for rewiring molecular-scale forces and assemblies and directly probing mechanics inside dividing
mammalian cells. More broadly, this work will serve as a platform for understanding the emergent architecture,
mechanics and computation of diverse macromolecular machines.

Public health relevance
PROJECT NARRATIVE During cell division, each daughter cell must inherit exactly one copy of each chromosome as errors can lead to cancer and birth defects. Two large cellular machines are responsible for segregating chromosomes: the spindle and kinetochore. Here we probe how these machines’ building blocks together give rise to their function, aiming to uncover the mechanical design principles driving chromosome segregation and to ultimately better target dividing cells for therapeutic purposes.